Modular Toolbox of Protein and Lipid Hybrid Biomaterials for siRNA Delivery

ABSTRACT/PROJECT DESCRIPTION:
Technologies for gene delivery are desperately needed to address a wide array of pathological processes in the
various tissues of the body. In particular, effective therapies for diabetic skin wounds poses a significant clinical
and scientific challenge due to heightened health care costs and increasing incidence of diabetes worldwide.
Recent progress in biomaterial-based gene delivery has ushered in promising options to treat chronic wounds
via localized effects; however, degradation or interception of precious nucleic acid therapeutic cargo in transit—
especially after unsuccessful escape from their endocytic vesicle—contributes to underwhelming transfection
efficiencies that render these technologies insufficient for clinical translation and an unmet need. The overall
objective of this proposal is to construct a modular arsenal of versatile, multi-functional supercharged proteins
and lipids that can be co-formulated into a hybrid nanovehicle, termed lipoproteoplex (LPP), for the delivery of
short interfering RNA (siRNA) sequences. We seek to improve the efficiency and safety of the LPP technological
platform by delving into its unique mechanism of cellular entry and cytosolic uptake. We propose the central
hypothesis that engineered proteins serve as the core, functional component of the LPP, dictating cargo binding
strength, whereas the outer lipid component serves to protect the payload. Both items collectively contribute to
and influence the bulk LPP's mechanism of cellular entry and cytosolic uptake. By harnessing a computationally-
informed experimental approach, we will generate novel cationic supercharged protein sequences and study
their interactions with various lipid shells to enhance the overall effectiveness of our LPP platform technology for
siRNA delivery. We will pursue this optimized formula through the following specific aims: (1) expand the cationic
supercharged protein library with viral tagged mutants to maximize the amount of endosomal escape while
balancing gene binding capabilities; (2) evaluate the role of the LPP's outer liposome on payload protection and
vehicle self-assembly; and (3) elucidate the LPP's cellular uptake mechanism essential for efficacious delivery
of siKeap1 in a murine humanized diabetic wound model. The expected outcome of this proposal is an adaptable
LPP formulation optimized to address the critical disease model of diabetic ulcers and wounds by promoting
wounded skin repair in a pre-clinical hyperglycemic environment. Beyond the proof-of-concept validation model,
the long-term goal of our work is to rationally design the LPP formulation for other siRNA sequences to have a
positive translational impact on a wide array of monogenic cutaneous disorders.
While other approaches focus
on chemically modifying the vehicle, our innovative approach focuses on the LPP's easily-modulated and
scalable components as the key driver of nucleic acid loading and subsequently successful delivery.
The
proposed research will determine significant structure-property-function relationships in the LPP's protein and
lipid components, which are quintessential to designing a harmonized LPP formula that can overcome the
endosomal escape barrier and achieve ultraefficient cytosolic siRNA delivery.

Public health relevance
PROJECT NARRATIVE: Efficient, non-toxic delivery of nucleic acid sequences into the cytosol remains the largest bottleneck precluding the development of potent RNA interference technologies that combat diseases in a non-palliative manner. Accelerated treatment of chronic diabetic wounds, our specific disease model of interest, remains a major ongoing challenge in medicine.